NONFOULING COATINGS ON GAS DISCHARGE TREATED SURFACES

The major goal of this project are to apply the power and versatility of plasma discharge processing and polymer chemistry: (1) to elucidate the mechanism by which certain polyether-coated surfaces are able to resist non-specific protein adsorption or cell adhesion, (2) to develop optimized polyether compositions and practical methodologies for immobilizing such non-fouling compositions on a variety of biomedically important materials used in implants, biosensors, immunoassays, bioprocesses and bioseparations, and (3) to demonstrate the utility of such coatings for an implant (small diameter vascular graft) and a diagnostic test (ELISA immunoassay).